Prostate Cancer Program

Prostate Cancer Program: Summary/Abstract
The overarching scientific goal of the HDFCCC Prostate Cancer (PR) Program is to use a team approach to
advance the understanding of tumor biology and drive translation into more effective and targeted treatment.
This is done through translational research spanning discovery bench science to clinical application and back.
The PR Program also seeks to specifically address the burden of prostate cancer and disparities in outcomes
among patients within the catchment area. The result will be a reduction the morbidity and mortality associated
with prostate cancer and its treatments by leveraging a deep understanding of the disease at the biologic,
clinical, and population levels. The PR Program approaches this mission with transdisciplinary research that is
richly collaborative and translational, organized around three specific aims: (1) to discover molecular features
and drivers of prostate cancer; (2) to develop and validate biomarkers and models to predict outcomes in men
with prostate cancer; and (3) to develop clinical interventions to improve outcomes for men with prostate
cancer.